Mechanisms of HIV-associated Hypertension

PROJECT SUMMARY
Over the last few decades, the advent of combination antiretroviral therapy has led to a profound suppression of
HIV replication and dramatically increased life expectancy in people with HIV (PWH). As a consequence, the
spectrum of diseases related to HIV has shifted from opportunistic AIDS-related disorders towards a premature
aging phenotype including an early onset of cardiovascular disease (CVD). CVD is now the leading cause of
death in PWH, however, the etiopathology of the accelerated development of hypertension, the leading risk
factor for CVD, has yet to be determined. Herein, we will test whether HIV derived proteins, which remain in
circulation despite cART and well-controlled viremia, contribute to the development of hypertension. We provide
novel exciting preliminary data in the Tg26 mouse model of HIV supporting a role for T cell-derived HIV proteins
and inflammation in vascular dysfunction, sympatho-activation, and hypertension. We demonstrate that
expression of HIV-derived proteins in Tg26 mice increases circulating Interleukin-1α (IL-1α), impairs
endothelium-dependent relaxation, increases sympathetic activity, and induces hypertension in male and female
mice. Remarkably, we show that transplant of bone marrow from Tg26 to wild-type (WT) mice recapitulates the
cardiovascular phenotype of intact Tg26 mice. Moreover, inhibition of T lymphocytes (T cells) activation restores
blood pressure (BP) and sympatho-activation and improves endothelial function in Tg26 mice. Conversely,
exposure of WT aortic rings to Tg26 T cells in a novel “T cells-vessel” co-culture system impairs endothelial
function and incubation with an anti-IL-1α antibody abrogates Tg26 T cell-mediated endothelial dysfunction. We
also show that endothelial dysfunction involves increased expression of the NADPH oxidase homologue Nox1
and that deficiency in Nox1 protects against Tg26-induced hypertension and endothelial dysfunction. Strikingly,
we provide very preliminary evidence of higher IL-1α transcriptional levels in CD4+ T cells from PWH and show
that aorta specimens discarded from PWH exhibit higher Nox1 expression than that from HIV- individuals. In
addition, exposure of human aorta specimen to Tg26 T cells media elevates Nox1 expression. Finally, we report
that infusion of the viral protein Tat in mice impairs endothelial function via Nox1-dependent mechanism.
Together, these exciting and novel findings inform the core hypothesis of this proposal: HIV Tat protein derived
from CD4+ T cells induces hypertension via IL-1α and Nox1 dependent mechanisms. We will test this hypothesis
in three aims. In aim 1, we will test whether HIV-associated hypertension involves CD4+ T cell-mediated, IL-1α-induced endothelial dysfunction and sympatho-activation. In aim 2 we will investigate whether IL-1α accelerates
vascular aging and promotes hypertension through Nox1 and senescence-mediated endothelial dysfunction,
while aim 3 will test the hypothesis that HIV-derived Tat protein promotes IL-1α-production from T cells and
hypertension. We anticipate that this proposal will lead to the identification of the new therapeutic targets to
prevent the accelerated development of CVD exhibited by people with HIV.

Public health relevance
PROJECT NARRATIVE Despite the advent of combination antiretroviral therapy, people with HIV (PWH) suffer from an accelerated development of cardiovascular disease, which drastically reduces their life expectancy. Despite this knowledge, the mechanisms predisposing PWH to high blood pressure, the leading risk factor for cardiovascular disease remain ill-defined and unstudied. The proposed study will combine the use of novel genetically engineered animal models, human specimens, and cultured endothelial cells with pharmacological approaches to test whether HIV derived proteins accelerate cardiovascular aging via inducing hypertension.